BD-STEPS II (Birth Defects Study To Evaluate Pregnancy exposures) - Core (Component A) & Steps Stillbirth (Component B)

Project Summary / Abstract
The Massachusetts (MA) Center for Birth Defects Research and Prevention (MCBDRP) proposes to continue
its strong track record of conducting etiologic research to identify modifiable risk factors for structural birth
defects through its participation in the Birth Defects Study to Evaluate Pregnancy exposureS II (BD-STEPS II).
We will enhance our contributions by leveraging our longstanding relationship with local universities to produce
future birth defects researchers. The MCBDRP brings to BD-STEPS II our expertise and leadership in
pharmacoepidemiology and collaborative utilization of unique data resources to be applied to all three key
areas of interest named in the Notice of Funding Opportunity. Our research will utilize existing data from the
National Birth Defects Prevention Study, BD-STEPS I and data to be collected as part of BD-STEPS II. The
MCBDRP investigators are committed and successful mentors and collaborative partners, roles that will
continue and expand within BD-STEPS II. Over the five year grant period, the MCBDRP will complete at least
10 etiologic research projects of public health significance that will aid in counseling women in considering
exposures that are less likely to result in a birth defect; these projects include: 1) Evaluating nicotinamide
adenine dinucleotide pathway inhibitors and the potential preventive effect of supplementation with niacin; 2)
Examining anti-viral medications, which are key to preventing maternal-fetal transmission but little is known on
their safety with respect to birth defects; 3) Assessing anti-obesity medications that have been and will
continue to be approved by FDA and assessing bariatric surgical procedures that are increasingly performed;
4) Investigating attention deficit hyperactivity disorder medications, the use of which has increased
dramatically; 5) Gauging the complex relationship among multiple risk factors to further our understanding of
birth defects; 6) Exploring trends in medication use in pregnancy to identify drugs that are becoming relatively
commonly used in pregnancy; 7) Leveraging the State Lab's reportable disease database to explore the role of
infections before and during pregnancy on the development of birth defects; 8) Considering folate pathway co-
factors, that support the one-carbon metabolism pathway, and their role in neural tube development; 9)
Exploring limb reduction deficiencies that are accompanied by amniotic bands and terminal transverse limb
defects to understand if they share common risk factors and pathogenesis; and 10) Harnessing this unique
data source to assess the relative risks/safety in pregnancy of newly-introduced medications, which is essential
given there is no ongoing, systematic approach to monitor drug safety in pregnancy in the US. For our
medication validation pilot study we will consider prescription drugs derived from the initial prescription
(medical record), pharmacy dispensing (claims data) and maternal report of use (prospectively collected data
in a mobile application). Through these activities, the MCBDRP will be an essential partner in BD-STEPS II to
achieve our overall goal of translating research findings into meaningful initiatives in birth defects prevention.

Public health relevance
Project Narrative The activities and projects proposed in this application are designed to test or generate specific hypotheses of considerable etiologic importance, with the ultimate goal of informing clinical and public health prevention messages and interventions to reduce the occurrence of birth defects. The vast majority of pregnant women take medications, yet in regard to risks of birth defects, we know little about the safety of most of these medicines; given this critical knowledge gap, many of our proposed projects focus on detailed analyses of maternal illnesses and medications as risk factors for birth defects. We will employ novel approaches including assessing post-marketing safety of newly introduced medications, leveraging datasets uniquely available to our collaborative, and focusing on underlying mechanisms of exposures.